Mucosal T cell memory to pathogens

PROJECT SUMMARY
Iterative T cell stimulation can result in senescence, exhaustion, or death (SED) as observed during chronic viral
infections, certain heterologous prime boost (HPB) vaccination studies, or cancer. Knowing whether there are
axiomatic limits to T cell clonal expansion is a critical gap in knowledge relevant for immunotherapy of diverse
diseases as well as fundamental understanding of immunobiology. In pilot experiments that began >8y ago, we
identified a stimulation strategy revealing that memory CD8 T populations are essentially infinitely expansible,
our oldest population having gone through 38 booster immunizations over 3200 days (longer than any mouse
lives) and effectively producing >1030 progeny. We hypothesize that this proof-of-principle, extreme-of-nature
experiment reveals fundamental T cell biology highly relevant to our understanding of the immune system and
provides unexpected observations that could be exploited for medically relevant purposes. We will leverage this
unique resource (ISTCs, iteratively stimulated T cells) to explore the consequences of iterative stimulation on T
cell biology. We will address the rules for avoiding SED despite repeated stimulation, the relevance of ISTCs
expressing exhaustion-associated genes without appearing functionally exhausted, and the mechanisms by
which ISTCs durably retain the unique effector-like property of circulation between blood and mucosal tissues.
Aim 1. To define the regulation and evolution of the ISTC differentiation program. We will 1) define
the evolution of ISTCs at the single cell level using bioinformatic and computational biology approaches, 2) define
rules for avoiding T cell SED by modifying the parameters of our stimulation strategy, and 3) contrast ISTCs from
exhausted T cells (Tex) on a molecular level by comparing gene expression patterns of Tex and consecutive
generations of ISTCs. We will test the hypotheses that 1) everlasting proliferative capacity depends on avoiding
terminal differentiation of a ‘stem’ population, 2) excessive division over a short period of time promotes terminal
differentiation, and 3) despite sharing key features with exhausted cells, functional ISTCs will reveal discrete
patterns of gene expression thus refining the molecular definition of exhaustion.
Aim 2. To define ISTC recirculation properties, mechanisms of immunosurveillance, and
antimicrobial functions. ISTCs represent a unique opportunity to interrogate mechanisms of nonlymphoid
tissue recirculation. We will 1) define the migration properties of ISTCs using parabiosis surgeries,
photoactivatable mouse lines, and perturbing homing molecules, 2) assess the protective potential of ISTCs in
a LM-N challenge model, and 3) extend these findings to ‘dirty’ mice (mice which have been iteratively exposed
to natural pathogens) and humans. We will test the hypotheses that 1) ISTCs recirculate through NLTs, 2) ISTCs
can protect against pathogen challenge, and 3) ISTCs can be identified in ‘dirty’ mice and humans.

Public health relevance
PROJECT NARRATIVE Repeated stimulation (e.g. chronic viral infections and exposure to tumor microenvironments) drives T cell senescence, exhaustion, and death. We have devised a T cell stimulation strategy that allows for seemingly everlasting expansion of functional T cells that retain the property of constitutive migration to nonlymphoid tissues. This unique resource will enable us to define features of T cell stimulation that permit everlasting expansion without compromising cell functionality, identify mechanisms of T cell migration to mucosal tissues, address gaps in our understanding of immunosurveillance, and will provide knowledge that may be exploited for vaccination and adoptive cell therapies.